RELATIONSHIP BETWEEN CREATININE AND LEAN TISSUE MASS DETERMINED BY DEXA

This study will determine which nutritional/biochemical variables (with particular emphasis on creatinine) best correlate with and/or predict lean tissue mass in hemodialysis patients by: (1) assessing fat, lean tissue, and bone mineral; (2) correlating DEXA-determined lean tissue mass; and (3) determining whether pre-dialysis cholesterol is correlated with and/or predicts fat mass.